Centralized Research Instrumentation Core (CRI)

Project Summary
The overall goal of the PR-INBRE Centralized Research Instrumentation (CRI) Cores is to
integrate and empower Faculty investigators, students and postdocs from the Lead, Primarily
Undergraduate Institutions (PUIs), and Outreach Institutions by providing mentorship and
scientific support. The PR-INBRE CRI will incorporate core facilities supported by PR-INBRE and
other collaborating facilities supported by National Institutes of Health (NIH) infrastructure
programs such as the National Institute on Minority Health and Health Disparities (NIMHD)-funded
University of Puerto Rico Medical Sciences Campus (UPR-MSC) RCMI program, and with UPR
institutional funds. Several of these core facilities have been operating for 14 or more years with
M.S. and Ph.D.-level experienced technicians and committed scientific staff. The following
facilities will participate in the proposed CRI in the next cycle: the RCMI/PR-INBRE Human
Genetics and Genomics Core Lab at UPR-MSC; the PR-INBRE Metabolomics Core at UPR-
MSC; the PR-INBRE Sequencing and Genomics Facility at UPR-Rio Piedras; the PR-INBRE
ChEMTox Biotesting Core at Universidad Ana G. Mendez Cupey Campus and the PR-
INBRE/RCMI Translational Proteomics Core at the UPR-Comprehensive Cancer Center. Their
efforts support local, national and international collaborations. To fulfill the overall goal of this
Core the following specific aims are proposed: 1) Continue to provide access to state-of-the-art
core research instrumentation for nurturing new research projects and expanding established
research collaborations between the CRI investigators, students, and postdocs from Puerto Rico
and other IDeA states. 2) Ensure the effective dissemination of technologies offered by the CRI
Cores via theoretical and practical workshops, mentoring researchers in experimental design,
data analysis and best practices in the use of the resources available at the CRI Cores. 3)
Collaborate with other INBRE and COBRE Core labs to expand access for PR-INBRE
investigators to innovative technologies available at other IDeA cores and provide opportunities
for professional development of technical and scientific staff by supporting attendance to
professional meetings such as the Association of Biomedical Research Facilities (ABRF) and
other training opportunities. To assist in the development of an interdisciplinary research effort
at the PR-INBRE network institutions, the CRI will provide specialized services such as: direct
technical consultation on experimental design, data generation, and analysis in genetics and
genomics in human and small animal model systems, proteomics, metabolomics, and biological
testing of experimental compounds in bacteria and tissue culture cells.